Core 2

SUMMARY
The goal of the Molecular Pathology and Immunology Core (Core 2) is to provide a centralized technical
infrastructure, inclusive of materials and the technical expertise necessary to accomplish all tissue-based
investigations including the collection of tissue samples, histopathological analysis, immune monitoring and
maintenance of a centralized database. Core 2 will function as the main repository of patient specimens and
will oversee specimen processing and histopathology. Collected tissue samples will be analyzed for P01
project specified tumor biomarkers and phenotyping of tumor immune infiltrates utilizing immunohistochemistry
for tumor biomarkers and mass cytometry and single cell RNA sequencing for immune cell phenotyping. Two
experienced lung pathologists and an expert immunologist will work closely with the Bioinformatics and
Biostatistics Core 3 and the Administrative Core 1 to ensure coordinated procurement, archiving, and storage
of human tissue samples (especially clinical trial specimens) and seamless integration of the data generated
from tissue-based investigations, including from mouse models and clinical trials, into a secure, database for
utilization and further analysis by Cores 1 and 3 and P01 projects. All tissue-based research will be performed
with ethical research oversight from IRB and IACUC protocols. Continuous communication between the
clinicians, scientists, research nurses, biostatisticians, bioinformaticians and pathologists together with
established standardized operating procedures for all core activities will provide optimal tissue collection,
processing, analysis, and data sharing for all projects.

Public health relevance
NARRATIVE The Molecular Pathology and Immunology Core 2 will collect and store tissues from patients with lung cancer, and will characterize these tissues using pathologic, genomic and immunologic tests. The Core will provide the tissues and the associated clinical, pathological, immunologic and genomic information to the investigators of all three of the proposed translational projects and to the biostatistics core for integration into a specialized lung cancer P01 database. These studies will help us understand lung cancer better and potentially allow us to develop new treatments for about one quarter of all lung adenocarcinoma patients whose tumors carry LKB1 mutations.